EEG AND ERP EVALUATION OF CHILDREN WITH FETAL ALCOHOL SYNDROME

The aims are to use electrophysiological and neuropsychological measures, spontaneous EEG and evoked responses, to assess central nervous system functions in school-age children, and to correlate these findings with other clinical data on the children, such as neurophysiological testing and MRI scans.